Adaptation and Testing of an Evidence-Based Sexual Health Communication Skills Training Intervention for Patients with Prostate Cancer

Prostate cancer (PCa) is the most common non-cutaneous cancer in U.S. men and causes sexual dysfunction
in up to 90% of patients. Sexual dysfunction is associated with long-term reductions in psychological health
and quality of life. Addressing sexual dysfunction is a critical component of PCa care that requires effective
patient-provider communication, as communication facilitates access to evidence-based sexual dysfunction
therapies. Our prior qualitative studies identified gaps in patient-provider communication about sexual health
as a key barrier to patients’ sexual recovery. Although most U.S. patients receive sexual health counseling
from PCa providers, many patients do not discuss their sexual health concerns with providers despite a desire
for help. PCa patients face significant barriers to communicating with providers about sexual dysfunction,
including loss of confidence due to impaired masculinity as a result of dysfunction. Furthermore, lack of patient
communication about sexual health is associated with worse quality of life. Although there is a critical need for
an intervention to improve PCa patients’ sexual health communication with providers, no efficacious
interventions exist. Starting the Conversation (STC) is an evidence-based sexual health communication skills
training intervention that has proven efficacious in improving breast cancer patients’ self-efficacy for sexual
health communication with providers, rates of sexual health communication with providers, and sexual health.
STC is a patient-facing, self-directed, multimedia intervention, and the core elements of the skills training are
broadly applicable across cancer type and stage. However, in its current format, STC focuses on female
cancer survivors’ sexual health concerns and does not address PCa patients’ barriers to communication.
Therefore, to address the critical need for an intervention to improve PCa patients’ sexual health
communication with providers, we propose to rigorously adapt STC for PCa and to pilot test the adapted
intervention. In Aim 1, we will conduct focus groups with PCa patients and individual interviews with PCa
providers to identify barriers and facilitators of patient-provider communication about sexual health in PCa care
and elicit feedback to adapt STC for PCa. In Aim 2, we will conduct usability testing with PCa patients to refine
the intervention. In Aim 3, we will conduct a pilot randomized controlled trial of STC adapted for PCa to assess
feasibility outcomes and preliminary effects of STC on patients’ self-efficacy for sexual health communication
with providers, rates of sexual health communication with providers, and sexual health. Conducting this study
will contribute to Dr. Gupta’s development into an independent investigator with expertise in sexual health and
urologic cancer survivorship, community engagement in research, development of behavioral interventions
(with a focus on patient-provider communication), design and conduct of behavioral intervention trials, and
dissemination and implementation science. Findings from this study will generate preliminary data for a future
NCI R01 submission for a definitive efficacy trial of the proposed intervention.

Public health relevance
Prostate cancer (PCa) is the most common non-cutaneous cancer in U.S. men and causes significant short- and long-term sexual side effects (i.e., sexual dysfunction) in up to 90% of patients. Although multiple evidence-based therapies for sexual dysfunction (e.g., psychotherapy, medications, surgery) exist, many PCa patients face significant barriers to communicating with their providers about sexual dysfunction, which impairs sexual recovery. We propose to rigorously adapt and pilot test an evidence-based sexual health communication skills training intervention for PCa patients to improve patient-provider communication about sexual health in PCa care and, thereby, facilitate improved sexual recovery and sexual health outcomes among PCa patients.